Biostatistics and Data Science Core

Biostatistics and Data Science Core (BDSC) - Project Summary
The objective of the BDSC is to provide state-of-the-art support in data management, high dimensional
complex data science and bioinformatics, and cutting-edge biostatistical and geospatial analysis to meet the
data management and analysis challenges of working with environmental exposure mixtures, and to advance
the environmental health research performed by the NM-INSPIRES Center investigators. The BDSC will be co-
led by Drs. Li Luo and Yan Guo. Dr. Luo has over 10 years of experience in high dimensional data analysis,
environmental chemical mixture modeling, causal inference, genetic-environment interaction and integrative
analysis, and statistical analysis of data from large scale population-based epidemiological and clinical studies.
Dr. Luo has lead the data management and analysis team supporting multiple NIH-funded environmental
health research projects and programs for over 3 years. Dr. Guo is a Bioinformatics expert who is the Director
of the Bioinformatics Shared Resources at the University of New Mexico Comprehensive Cancer Center. Dr.
Guo’s research has been focused on the development of bioinformatics methodology and analysis approaches
for cancer genomic studies and has published more than 150 manuscripts in the related fields. Core members
include eight quantitative scientists with complementary expertise in data management and analysis for a
variety of scientific domains. Core members have backgrounds and expertise in a wide range of quantitative
research methodologies, including modern FAIR compliant data management, biostatistical methods,
bioinformatics tools, geospatial analysis and modeling, survey data analysis, Bayesian methods, and causal
inference. The team members have collaborated for many years on multiple environmental health projects, and
have streamlined the workflow from data collection, quality control, bioinformatics, biostatistical and geospatial
analysis support, and methodology developments to enhance the analysis of environmental health data sets.
The Core will serve as a hub for all research activities of the Center and provide a wide array of analytical
support to Center investigators engaging in environmental health research. The BDSC support will contribute
to many aspects of the research process including, but not limited to, efficient study design, appropriate
monitoring of data security, enhanced data management capacity, state-of-the-art bioinformatics, biostatistical
and geospatial analyses, assistance in the development of study protocols and proposals, as well as sample
size and power calculations. Core faculty will also provide educational opportunities to Center investigators and
trainees through lectures, classroom teaching, workshops, and hands-on training. The collaborative efforts of
Core members will contribute not only to effectively pursuing hypothesis-driven research questions but also to
developing novel research questions through complex analyses of large datasets. BDSC is well positioned to
promote multidisciplinary and interdisciplinary research and develop analytical strategies to contribute to the
successful completion of basic, community-based, and translational research projects within the Center.